3-D Visualization and Prediction of Vertebral Fractures

Vertebral fractures (VF) afflict more than 25% of people over age 50, and their burden is growing. Current
approaches for estimating VF risk, which rely heavily on measurement of the average bone mineral density
(BMD) in the vertebra, are known to be insufficient, but the search for better diagnostics is hindered by poor
understanding of the pathogenesis of VF. Increasing evidence suggests that the risk, mechanisms, and
outcomes of VF depend critically on the interaction of tissues near the interface between the vertebra and the
intervertebral disc. This endplate region is defined as the cartilage endplate (CEP), the bony endplate (BEP),
and the subchondral trabecular bone (STB). The disc mediates how the net force borne by a given vertebra is
distributed over the surface of the endplate (“endplate loading”), and the endplate region mediates how this
force distribution is transferred to the rest of the vertebra. The mechanical behaviors of the disc and endplate
region are therefore expected to affect when and how the vertebra fails. Indeed, we have found that VF in
elderly vertebrae commonly initiate within the endplate region, and that the way this region fails is influenced
by not only the microstructure of this region but also the extent of degeneration in the adjacent disc. Moreover,
recent data suggest that the mechanical behavior of the endplate region may change with aging and disc
degeneration in ways that are not well predicted by the average BMD of the vertebra. These collective findings
reveal a paradigm in which delineation of the biomechanical interactions between the endplate region and disc
holds an important key to identifying risk factors for VF and, consequently, to reducing the incidence and
burden of VF. As such, the overall goal of this project is to define how degeneration and aging of the disc
and endplate region influence the mechanisms of VF. Aim #1 will quantify the dependence of endplate loading
on disc degeneration and will use non-invasively obtained estimates of endplate loading to develop accurate,
patient-specific, finite element (FE) simulations of VF. This Aim will capitalize on recent advances in magnetic
resonance imaging (MRI)-based assessments of the disc to achieve a novel integration of the state-of-the-art
in clinically feasible FE models of the disc and vertebra. Aim #2 will address the current paucity of data on the
biomechanics of the endplate region. Using mechanical testing, µFE modeling and biochemical assays, we will
identify the extent to which properties such as the brittleness of the BEP, strength of the STB, and stiffness of
the CEP change with age and disc degeneration. Aim #3 will focus on the way in which the endplate region
fails during VF. Motivated by clinical and pre-clinical observations that disc health declines more rapidly
following VFs that involve fracture of the BEP, as opposed to those that involve failure of only the STB, we will
use both experiment and large-scale µFE models to identify characteristics of the disc and endplate region that
are associated with BEP fracture. Altogether, these three Aims constitute a mechanistic, innovative, and
interdisciplinary approach that will enable a step change in the understanding, prevention, and treatment of VF.

Public health relevance
One in three women and one in six men over age 50 will suffer a spine fracture in their remaining lifetime. This project focuses on determining how age-related changes in the structure of a key region of the bone in the spine, and degeneration of the intervertebral discs adjacent to this bone, affect the likelihood of fracture.